ReCARDO: Using Real-World Data to Derive Common Data Elements for Alzheimer's Disease and AD-Related Dementias Research Through Ontological Innovation

Project Summary
Common Data Elements (CDEs) are metadata standards serving as a foundation for semantic interoperability,
a prerequisite for leveraging disparate Real-World Data (RWD) sources for secondary analysis. Existing efforts
in AD-related metadata development include the National Alzheimer’s Coordinating Center’s (NACC) Uniform
Data Set and NINDS CDEs. These are parts of an important metadata collection for AD/ADRD research, but
existing CDEs are not designed, developed, and sufficiently validated to transform NIA-funded studies through
the generation of Real-World Evidence (RWE) from RWD with data linkage and longitudinal analyses.
In this U24 project, “ReCARDO: Using Real-World Data to Derive Common Data Elements for Alzheimer’s
Disease and AD-Related Dementias Research Through Ontological Innovation,” we propose to create a ten-
institution research network for developing an AD/ADRD-focused, collaborative data ecosystem incorporating
CDEs to leverage RWD for empowering NIA-funded studies, and for enhancing the transparency, rigor and
reproducibility of AD/ADRD research. Our aims cover the development (Aim 1), application (Aim 2), and
dissemination (Aim 3) of AD/ADRD CDEs and AI/ML/NLP tools through this national collaborative ReCARDO
Research Network (RRN). These aims will be achieved through the organization of the RRN in seven Work
Streams: 1. CDE development and CDE knowledge graph; 2. CDE extraction from RWD; 3. Data, metadata,
and resource ecosystems; 4. AI/ML/NLP and computational phenotyping; 5. Research questions, use cases,
and CDE application, including a pilot study program; 6. Genetics, imaging, biomarkers and big data; and 7.
Reproducibility and evaluation. Administrative support (Aim 4) will be provided through five Key Functions:
Steering Committee (SC) and External Advisory Panel (EAP); Management and support for Work Streams,
annual meeting, and the pilot study program; Innovation capacity development; Governance framework
adopting best practices; and Dissemination and outreach activities, including a project Web Portal.
This project is significant because it creates an ecosystem approach to addressing data harmonization and
reproducibility challenges in maximizing the value of RWD through partnership among ADRCs. This project is
innovative because it builds on the latest data science and ontological advances to ensure sustained impact in
a federated data ecosystem incorporating AD-CDEs for translating RWD to RWE. Our novel conceptual project
framework is designed to bring together teams and ensure the effective operation and impact of the RRN in a
milestone-driven, collaborative setting, led by a group of world-class data scientists working side-by-side with
some of the most established domain experts in AD/ADRD. Success of ReCARDO will revolutionize our
approach to translational data-driven discovery in AD/ADRD research, for decades to come.

Public health relevance
Project Narrative We propose to create a collaborative national research network to empower and enrich NIA-funded studies through a growing semantic-rich Real-World Data ecosystem. The resulting harmonized, validatable, cross- sectional and longitudinal data resources will enable effective reuse of disparate and unaligned Real-World Data to power collaborative research on Alzheimer's disease and AD-related dementias (AD/ADRD). Ultimately, efforts from this project will accelerate the generation of new knowledge that leads to life-changing strategies for the prevention, detection, management, and treatment of AD/ADRD.